Adventitial Fibroblast Phenotypic Modulation in Atherosclerosis

PROJECT SUMMARY
New avenues of therapy for atherosclerotic diseases are needed as they remain the leading killers worldwide.
Therapies that target each of the different cell types that influence the formation of atherosclerotic plaque have
translated into lifesaving therapies. Characterizing a novel key cell population that plays a pathogenic role in
atherosclerosis will open entirely new avenues for therapies. Our preliminary single cell transcriptomic data and
histology of human and murine atherosclerotic plaque have identified an understudied population of cells that
we define as Adventitial Fibroblasts (AdvFib). Enabled by an innovative genetic tool, our preliminary data has
unveiled a previously unrecognized non-cell-autonomous role of AdvFib in plaque biology. AdvFib ablation or
modification of AdvFib through GWAS gene TCF21 significantly influences atherosclerotic plaque formation and
calcification. Identification and validation of previously unrecognized outside-in signals affecting atherosclerotic
plaque using state-of-the-art techniques form the central focus of this proposal and will lead to novel therapies.
Our study is highly innovative by focusing on an overlooked population of vascular cells. No current therapeutic
targets these cells. Previous studies of adventitial cells were limited by the inability to deconvolute the causal
cell type and relevant disease-related pathology due to cellular heterogeneity of the adventitia and lack of a
specific tool to track the fibroblast lineage. Our innovative approach overcomes the shortcomings of previous
adventitial studies by using single cell genomics tools, a new and unique murine model that we designed
specifically to study vascular adventitial fibroblasts, and complementary in vitro human primary cell models.
Aim 1 will determine the mechanism behind the observation that even though AdvFib do not contribute to the
intimal lesion, targeted genetic ablation of AdvFib significantly decreases plaque formation. We will use our novel
AdvFib-specific inducible CreERT2 murine model, inducible diphtheria toxin receptor, and single cell
transcriptomics with mechanistic validation using human AdvFib co-culture experiments. Aim 2 will determine
why conditional AdvFib deletion of Tcf21, a GWAS gene for coronary disease, alters plaque calcification. We will
accomplish this through a combination of single cell transcriptomic, epigenetics and in vitro human AdvFib
functional epigenetic mapping and detailed mechanistic validations. Aim 3 will test the potential therapeutic
potential of AdvFib-specific Tcf21 overexpression on plaque composition and vascular calcification. We will use
a combination of single cell transcriptomics using a novel murine model and in vitro human AdvFib studies.
Our rigorous team science approach synergizes expertise from diverse disciplines, including coronary artery
development, human genetics, epigenomics, and the innate/adaptive immune system. Completion of this project
will define the role of AdvFib in atherosclerosis, solidify AdvFib as a new target for therapy, and identify new
AdvFib disease-related pathways and genes that may also play a role in other vascular diseases.

Public health relevance
PROJECT NARRATIVE Adventitial Fibroblasts (AdvFib), a unique population of cells residing outside of the arteries, appear to be the earliest cell population activated during the development of atherosclerotic plaques. Our preliminary data suggest that AdvFib actively modulate other plaque cells’ behaviors, however, the exact mechanisms by which AdvFib influence plaque development is unknown. This study will combine detailed state-of-the-art phenotyping of our new AdvFib mouse models alongside mechanistic studies by using human AdvFib to understand how these cells influence atherosclerosis, and identify possible therapeutic targets that focus on these currently overlooked cells.